Structural and Functional Studies of the TRPM4 and TRPM5 Channels

PROJECT SUMMARY
Blood flow from the heart to the brain is strictly regulated to protect the delicate brain tissue, because improper
blood flow can give rise to numerous cardiovascular diseases and brain injuries. TRPM4 is one of the major
actors regulating blood flow in the vascular smooth muscle cells in the cerebral arteries when intracellular
pressure changes. Mutation or dysfunction of TRPM4 is linked to numerous cardiovascular diseases, including
stroke and Brugada syndrome. TRPM4 and its closest homolog, TRPM5, are Ca2+-activated, nonselective,
voltage-gated ion channels. TRPM5 is highly expressed in pancreatic beta cells, and dysfunction or mutation in
TRPM5 is associated in type II diabetes and obesity. In addition, TRPM4 and TRPM5 in the taste bud cells play
an important role in taste signaling, and loss of both channels abolishes the ability to detect bitter, sweet, or
umami stimuli. Both channels are modulated by temperature. Taken together, TRPM4 and TRPM5 have a wide
range of roles in physiology and pathophysiology.
Both TRPM4 and TRPM5 belong to the TRPM (melastatin-like transient receptor potential) subfamily of the TRP
superfamily, and they are the only two members impermeable to Ca2+. Over the past four years, our research
group, along with others, has made significant progress in elucidating the cryo-EM structures of TRPM4 and
TRPM5, paving a solid foundation for uncovering the ligand-dependent molecular mechanisms of TRPM4 and
TRPM5 activation and inhibition. However, we still do not understand, in molecular detail, how the channels are
modulated by temperature, how they are modulated by small molecules binding to them at specific sites at
physiological temperature, how they are distinguished by various drugs, or how their channel functions are
modulated by other proteins such as calmodulin.
We propose to continue the cryo-EM studies of TRPM4 and TRPM5 and their pharmacology, combined with
complementary electrophysiology experiments and collaboration with Takeda. The outcome of this proposal will
define the molecular basis for the temperature-dependent gating activity of these ion channels, for ligand
recognition, and for the action of modulators. These advances, in turn, will provide a foundation for developing
new therapeutic agents against cardiovascular diseases and diabetes and for a deeper understanding of the
function of the temperature-sensitive TRPM family members.

Public health relevance
PROJECT NARRATIVE TRPM4 and TRPM5, which are Ca2+-activated, nonselective, Ca2+-impermeable, voltage-gated ion channels, play key roles in cerebral artery constriction, immune response, insulin secretion, taste and temperature sensation, and are thus critically linked to cardiovascular diseases, diabetes, and transduction of taste stimuli. This research project will focus on the temperature-dependent gating mechanism of TRPM4 and TRPM5 and their pharmacology, taking advantage of single-particle cryo-EM and electrophysiological recording. The proposed research is relevant to public health and NIH’s mission, because the work will provide a deeper understanding and knowledge of the relationships between atomic structure and function in the temperature- modulated TRPM family members, as well as a foundation for developing new drugs for cardiovascular diseases and diabetes.